Myeloid Cells: Development, Diversity and Distinct Biological Roles

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Myeloid Cells: Development, Diversity and
Distinct Biological Roles, organized by Drs. Gwendalyn Randolph, Minsoo Kim, Roxane Tussiwand, and
Muzlifah Haniffa. The conference will be held in Snowbird, Utah from March 16-19, 2023.
It is becoming more evident that myeloid cells participate critically in a variety of physiological and
pathophysiological processes and that targeting myeloid cells, either at selected stages of their development or
as they mature, may be successfully harnessed in the treatment of cancers or infectious disease. The
application of rapidly evolving omics technologies are aiding in the quest to increase understanding of myeloid
cell diversity and the potential of targeting them therapeutically. However, at the same time, fundamental
questions about myeloid cell identity and function remain unknown. This Keystone Symposia conference will
address these frontiers as it aims to attract speakers and attendees across the full breadth of the field. The
conference program will include key talks intended to focus on the application of new technologies in the field,
the advances they bring, best-practice application, and potential complications in analysis. Significant focus
will also be given to the role of myeloid cells in cancer and metastasis, including the fast-growing area of how
neutrophils aid tumor metastasis. Basic science that covers myeloid cell development and function will be
interspersed with talks on the role of myeloid cells in disease states. In the last decades, the number of
outstanding scientists in the field has grown tremendously, and this conference will showcase this growth
through inclusion of many new dimensions in the field.

Public health relevance
PROJECT NARRATIVE Advances in molecular and cellular biology approaches have revolutionized our understanding of the diversity among myeloid cell populations. Furthermore, it is becoming clear that myeloid cells participate critically in a variety of biological processes and that by targeting these cells in research, it could lead to them being harnessed for use in the treatment of cancers or infectious disease. Therefore, this conference program was designed to broaden the perspectives of attendees, in turn fueling advances in the field by exploring innovative research themes and developing new connections.